Establishment of the WNY Spatial Biology Resource Center

Project Summary
The University of Rochester Medical Center (URMC) is committed to advancing research excellence by
providing state-of-the-art facilities and cutting-edge technologies for biomedical and biological research. Spatial
‘omics is transformative new technology that seeks to harness the power of ‘omics (eg. genomics, proteomics,
metabolomics, lipidomics) to provide a deep molecular profile of individual cells in a way that maintains the
spatial relationships that exist between cells and their surroundings in intact tissues. The URMC proposes the
establishment of the Western New York Spatial Biology Research Center (SBRC). This pioneering initiative will
integrate tissue processing, histology, genomics, and bioinformatics/data analytics into a unified organizational
entity, closely integrated with tissue and biobanking efforts. The 5,700 square feet of wet- and dry-lab space is
centrally located to researchers where the SBRC will serve as a comprehensive hub for spatial omics
research, enabling validation and discovery at an unprecedented scale. By centralizing URs expertise in
histology, genomics, and bioinformatics and positioning the SBRC near the Wilmot biobank, we will foster
innovative collaborations, enhance accessibility, and streamline research to accelerate scientific discovery. We
will develop data analytics excellence by establishing a modernized data analytics collaborative space,
equipped with advanced IT infrastructure, to enable the analysis of large-scale spatial ‘omics datasets and to
develop novel analytical techniques integrating multilevel ‘omics data. Additionally, the creation of this new
collaborative dry-lab space will catalyze interdisciplinary partnerships and the development of novel research
methodologies. Through dynamic collaborations with our regional and national partners, the SBRC will serve
as a central hub for transformative cross-disciplinary science. Our commitment to training the next generation
of researchers will ensure that scientists are equipped with cutting-edge skills in spatial omics, empowering
them to tackle urgent scientific challenges and discover life-changing cures. The SBRC is strategically
positioned to elevate translational research in key areas such as musculoskeletal diseases, cancer biology,
autoimmunity, and neuroscience. By providing researchers with access to cutting-edge methodologies, SBRC
will empower new scientific breakthroughs. Moreover, it aligns with the University of Rochester's educational
mission by offering advanced training in bioinformatics and data analysis, thereby broadening the adoption of
spatial omics across diverse research domains. This initiative represents a transformative step forward in
promoting research excellence at the University of Rochester and beyond. By fostering critical advancements
in health-related research and serving as a regional resource for translational discovery and education, SBRC
will solidify URMC's position as a leader in biomedical innovation.